Maternal Depression Calibrates Infants' Neuroendocrine, Autonomic, and Inflammatory Stress Responsiveness

PROJECT SUMMARY
The objective of the current proposal is to determine when and how infants' stress responsivity is calibrated by
maternal depression, and how this calibration translates into child emotional and behavioral problems.
Psychological health relies on the regulation of stress-responsive physiological systems—i.e., hypothalamic-
pituitary-adrenal (HPA) axis, autonomic nervous system (ANS), and inflammatory mediator (IM) responses
that match the demands of a given stressor and recover promptly once it has passed. It is important to clarify
how these systems become dysregulated in order to identify and intervene on risk trajectories. Previous cross-
sectional research highlights maternal predictors and child outcomes related to dysregulation of one or more of
these systems but fails to address the possibility that within-person development of stress responsivity across
systems offers a critical window into early risk. We will test the central hypothesis that early exposure
to maternal depression predicts sensitization of HPA, ANS, and/or IM function that
undermines the child's psychological health through the following specific aims: (1) Determine whether
maternal depression induces upward calibration of infant stress responsivity across systems; (2) Identify
maternal depression profiles with the strongest impact on infant stress calibration; and (3) [Characterize
maladaptive stress system development through associations between infant stress response trajectories and
deficits in self-regulatory functions.] A community sample of [250 expectant mothers—over half with a
diagnosed major depressive episode and the rest with no diagnoses]—will be recruited during pregnancy and
followed through the first 2 postnatal years. At 3, 8, 15, and 24 months the infant will be exposed to
developmentally appropriate interpersonal stressors to assess stress responsivity, with salivary cortisol tapping
HPA, alpha-amylase (sAA) tapping ANS, and a composite of IL-1b, IL-6, TNF-a, and CRP tapping IM
activation. Child self-regulatory development will be assessed via both mother-report and behavioral measures
at 24 months. We hypothesize that mothers' depression symptoms will predict child stress sensitization from
3-24 months, evidenced by a trajectory of increasing/nonrecovering multi-system activation over time. The
strongest effects are expected for early (prenatal, 3-month postnatal) depression symptoms in mothers who
have crossed a diagnostic threshold for a lifetime depressive disorder. We further expect child stress
sensitization—[especially high/increasing concordant activation across HPA and IM, but low/decreasing
concordance across HPA and ANS]—will predict poorer executive function and emotion regulation at 24
months. Achieving these aims will clarify how stress-responsive systems are calibrated by maternal depression
and how this calibration confers risk for later disorder. The findings will inform a truly developmental model of
stress-related dysregulation while defining novel stress physiology targets for early mother/infant intervention
to mitigate psychological health risks in children of depressed mothers.

Public health relevance
PROJECT NARRATIVE The purpose of this study is to determine how mothers' depression calibrates their babies' biological sensitivity to stress over time, and how this calibration translates into child emotional and behavioral problems. This will help to identify the roots of stress-related disorder and suggest targets for early intervention to interrupt the intergenerational transmission of stress-related health problems.